Epigenomic Dynamics of Clonal Hematopoiesis

PROJECT SUMMARY
The human body constantly replenishes blood and immune cells from stem cells in bone marrow through a
differentiation process termed hematopoiesis. Disruptions in this process can lead to hematologic malignancies.
Classically, hematopoietic fate decisions were modeled as discrete steps, but recent single-cell RNA sequencing
studies demonstrate that hematopoiesis is continuous and that fate restriction occurs even within the
hematopoietic stem cell population. These early fate decisions and the prevalence of epigenetic regulator
mutations in hematologic malignancies highlight the essential role of the epigenome in hematopoietic fate
commitment and the necessity of understanding these mechanisms at a fundamental level. Previous studies
have demonstrated that epigenetic priming occurs in hematopoietic stem cells, but techniques capable of
measuring these states in single cells have only recently become available. Utilizing single-cell measurements
of gene expression, chromatin accessibility, and histone post-translational modifications in healthy
hematopoiesis, I will develop computational tools to identify regulatory dynamics of cell fate gain and loss unique
to single lineages. To characterize dysregulation of regulatory dynamics in disease, I will knock in a clinically
relevant nonsense mutation in ASXL1, a regulator of histone H3 lysine 27 trimethylation, in human hematopoietic
stem cells, differentiate them in vitro, and assay gene expression, chromatin accessibility, and multiple histone
modifications in single-cell experiments to identify how these regulatory programs are disrupted and where in
the developmental trajectory this disruption occurs. This research will unravel the complex regulatory landscape
of priming and lineage biases in healthy hematopoiesis and improve the mechanistic understanding of
hematologic malignancies in need of improved therapies.

Public health relevance
PROJECT NARRATIVE Using single-cell measurements of gene expression, chromatin accessibility, and histone post-translational modifications in healthy hematopoiesis, I will develop computational tools to identify regulatory dynamics of cell fate gain and loss unique to single lineages and how their dysregulation drives clonal hematopoiesis.